2021 and 2023 Alcohol-Induced End Organ Diseases Gordon Research Conference

Abstract
Alcohol misuse is one of the world's leading preventable health risks. Alcohol use and abuse is a causal factor
in over 60 different diseases and injuries putting an enormous health and economic burden on societies
worldwide. The major share of alcohol-induced morbidity and mortality is attributable to alcohol-induced end
organ diseases, including cancer, alcoholic liver disease, pancreatitis, osteoporosis, diabetes mellitus,
hypertension, ischemic heart disease, arrhythmias, stroke, pneumonia and fetal alcohol syndrome. Alcohol use
disorders are on the rise in all segments of society and they often synergize with other diseases that have
reached epidemic proportions including obesity, diabetes, metabolic syndrome, drug abuse and immunological
maladies. Despite the significant advances of the field over the last two decades, the underlying disease
etiology is poorly understood and there is an urgent need to gain new knowledge of the molecular
underpinnings of alcohol-induced end organ diseases to accelerate diagnosis, prevention, and treatment. In
this R13 application, we are seeking support for the Gordon Research Conferences (GRC) Alcohol-induced
End Organ Diseases 2021 and 2023. This is a relatively new GRC, which was initiated three years ago held
extremely successful meetings in 2017 and 2019. The open format of GRC model includes sharing significant
unpublished work and provides ample opportunities for in-depth discussions with peers, new colleagues and
the future generation of alcohol researchers; this conference model is ideally suited for propelling the field to
new heights. The overall goal of the Alcohol-induced End Organ Diseases meetings are to foster open
discussion of research developments, establish new scientific collaborations, and propel the next generation of
scientific advances. This GRC fills a critical need in the field for a continuing meeting that presents key recent
findings on alcohol-induced end organ injury and repair in a unique format that ensures time for in-depth
discussions, formulation of new approaches and initiation of new collaborations. This conference will 1) provide
a forum that promotes open discussion of cutting edge research at the forefront of alcohol-induced tissue
injury, 2) foster the development of the next generation of alcohol and tissue injury investigators, 3) promote
interaction between young and senior investigators, 4) facilitate the exchange of ideas that will shape the future
directions of the alcohol and tissue injury community and 5) introduce breakthrough techniques that facilitate
the understanding of mechanisms driving alcohol-induced tissue injuries. We envision the GRC on “Alcohol
induced end organ diseases” will significantly advance current understanding of the underlying mechanisms of
end organ injuries and stimulate development of effective therapeutic strategies for the diagnosis, prevention
and treatment of alcohol use disorders.

Public health relevance
Project Narrative The Gordon Research Conference (GRC) on “Alcohol-Induced End Organ Diseases” will create a state-of-the- art forum for discussion of in alcohol research, including studies of acute and chronic alcohol exposure across the entire spectrum of lifespan on the significant and widespread detrimental organ system effects of alcohol. The conference will provide a unique forum to bring together a diverse range of young and established alcohol researchers, and experts in complementary fields, to discuss groundbreaking advances in how alcohol consumption results in tissue injury. The meeting format employed by the GRC facilitates open discussions, builds bridges in between investigators in different disciplines, as well as between preclinical and clinical investigators and fosters the development of the next generation of alcohol researchers.